the Diabetes Research for Equity through Advanced Multilevel Science Center for Diabetes Translational Research (DREAMS-CDTR)

Project Summary/Abstract
Diabetes mellitus is a significant health burden in the U.S. and California leads the nation in incident cases and
costs of Type 2 Diabetes. Individuals with low socioeconomic status, older adults, rural populations, and racial
and ethnic minorities are at highest risk. The drivers of these disparities include a complex combination of
interacting factors at the individual, family, community, health system, societal, and policy levels. Programs and
policies that can effectively translate high-quality, evidence-based diabetes interventions into widespread
practice across diverse communities, modes of delivery, and a range of settings are desperately needed. The
Diabetes Research for Equity through Advanced Multilevel Science Center for Diabetes Translational
Research (DREAMS-CDTR) aims to advance health equity science through the development and translation
of: 1) innovations and structural changes to healthcare delivery systems that substantively reduce health
inequalities, and 2) innovative, scalable interventions to alter the socioenvironmental drivers of the Type 2
Diabetes epidemic and associated disparities.
Focusing on the northern California and Central Valley regions of California, the DREAMS-CDTR will conduct
clinical research and interventions designed to inform practice and policy change at the health system,
community and policy levels. The DREAMS-CDTR (formerly Health Delivery Systems) brings together
translational science core faculty who have expertise in diverse, multi-level areas including: food insecurity,
medication adherence, health communication, health IT, social policy, and cost effectiveness analysis.
DREAMS-CDTR will involve four regional academic sites with a range of public and non-profit health systems
that serve large and diverse populations: Kaiser Permanente Northern California’s Division of Research and
the University of California at San Francisco, Merced and Davis.
The DREAMS-CDTR activities include: an Administrative Core, Pilot and Feasibility Program, Enrichment
Program, and three coordinated research cores - Health Equity & Action Translational (HEAT) core, Methods
and Data Integration (MDI) translational core, and National Diabetes Policy Research Resource (DPR) core.
The HEAT Core will employ a multi-level systems approach to designing rigorous action-oriented observational
and interventional research. The MDI Core will systematically prepare and support DREAMS-CDTR members
in harnessing novel advances in methods and data to achieve greater health equity in Type 2 Diabetes. Lastly,
the novel National DPR Core will extend the reach of the DREAMS-CDTR expertise and resources beyond the
primary institutions in five key areas of expertise: (1) natural experiments research,(2) health economics,
including comparative effectiveness and cost-effectiveness analysis; (3) simulation modeling, (4) machine
learning, and (5) communicating science to policy-making institutions, community partners, health
departments, and human service organizations.

Public health relevance
Narrative The purpose of this renewal application is to continue and refocus the work of the Health Delivery Systems Center for Diabetes Translational Research (HDS-CDTR) (P30 DK092924), renamed the Diabetes Research for Equity through Advanced Multilevel Science Center for Diabetes Translational Research (DREAMS- CDTR), on reducing diabetes related health disparities and improving health equity. Refocused on northern California and its Central Valley, the DREAMS-CDTR is a collaborative partnership between the Kaiser Permanente Northern California’s Division of Research and the University of California at San Francisco, Merced and Davis. This Center leverages expertise in two Core Translational Research areas of health equity and methods and data integration and from a national diabetes policy resources core to accelerate the translation of diabetes research into changes in healthcare delivery, public health practice, and policy.